Hybrid Delivery to Increase Access and Sustainability: Evaluating ezParent Implementation

PROJECT SUMMARY/ABSTRACT
Positive parenting practices (e.g., supportive, consistent, responsive) buffer the negative effects of early
adverse experiences by developing safe, stable, and nurturing environments. Positive parenting practices are
important in strengthening and creating positive childhood and supporting optimal child social and behavioral
development. Parent training (PT) is the gold standard for supporting and strengthening parenting practices
and preventing and treating child behavior problems. The primary method of delivering PT involves face-to-
face, in-person sessions. Although effective, there are multiple limitations with in person PT delivery affecting
access and reach (time; schedule conflicts; access to childcare, transportation, trained facilitators; stigma). The
PT program proposed in this study is the web-based adaptation of the evidence-based based Chicago Parent
Program (CPP), called ezParent. There is evidence suggesting web-based programs are more effective when
paired with human support, known as hybrid delivery. The overall purpose of this STTR fast-track project is to
develop and test tools to support implementation of hybrid ezParent using a community organization dedicated
to serving low-income families and young children (Head Start and Early Head Start (HS/EHS)) as a test site.
The proposed ezParent implementation bundle (ezParent program for parents, asynchronous web-based
facilitator training, and the ezParent dashboard) will be refined and usability tested in Phase I and parent, child,
and implementation outcomes evaluated in a cluster randomized trial in Phase II. In Phase I and in
collaboration with a Community Advisory Board (CAB) of HS/EHS stakeholders, specific metrics, components,
and features to include in the dashboard will be developed with the goal to enable robust tracking of program
use and support program tailoring. Then, in partnership with the CPP/ezParent developers, a 2-module
prototype of the hybrid facilitator training will be developed and evaluated by trained parent training facilitators.
In Phase II, the 4-module facilitator training and the ezParent bundle website with custom views for parents,
facilitators, and administrators will be completed. The ezParent bundle will be tested using a cluster
randomized trial in 16 HS/EHS sites (8 ezParent bundle/8 usual care) with HS/EHS personnel facilitators
(n=16-32; ~2 facilitators/8 intervention sites) and 516 parents (258/arm) of children aged 2-5 years old. The
ezParent bundle implementation outcomes will be examined from the site, facilitator, and parent levels using
RE-AIM (Reach, Effectiveness of implementation, Adoption, Implementation, and Maintenance). This study
addresses the NICHD STTR priority of developing and adapting technologies and products that support
healthy social and behavioral development and targeting underserved populations.

Public health relevance
PROJECT NARRATIVE Positive parenting practices help support optimal child social and emotional development. Parent training is considered a gold standard for supporting and strengthening parenting practices and for the treatment and prevention of child behavior problems. This study will develop and test a comprehensive implementation package (the ezParent Bundle) supporting the hybrid delivery of the ezParent Program with the goal of creating sustainable and accessible methods for community-based delivery.